Neuroscience Training Grant

Project Summary
This is a competitive renewal application for a Jointly Sponsored Institutional Predoctoral Training
Program in the Neurosciences (JSPTPN) for pre-thesis Ph.D. students in the Neuroscience Training Program
(NSP) at the University of Colorado, Anschutz Medical Campus (CU Anschutz). The NSP is an
interdisciplinary Ph.D. granting degree started in 1986 that has been funded by this training grant since 2001.
Presently, NSP has more than 70 faculty members of whom 55 are Training Faculty on this application. NSP
aims to train stellar graduate students who develop into independent, thoughtful, and critical thinking
neuroscientists who can succeed in the 21st century. This is achieved through broad-based training in
neuroscience that includes instruction in the fundamental concepts of neuroscience, diseases of the nervous
system, experimental design and statistical methodologies, literacy in quantitative methods, and the
responsible conduct of research. Further, our plan trains graduates who are not only high caliber academic
scientists but also well-informed about various career options and professionally well-equipped. These specific
objectives are achieved through coursework, mainly in the first two years of graduate school, and research
projects in training labs. In addition, concepts that are introduced to students in coursework are reinforced and
integrated throughout the student’s time in graduate school through various enrichment activities such as
seminars and journal clubs and close mentoring by faculty during benchmark exams and Ph.D. thesis
committee meetings. Our training plan has been continually enhanced over the years, especially in the area of
quantitative methods, reflecting the Program’s identification of these skills as critical for performing high caliber
research and for competitive placement of our graduates. Our mission is also to grow and sustain a diverse
and inclusive student body. Our training plan includes multiple evaluative components to help ensure
effectiveness. These include an annual evaluation by a Neuroscience T32 Advisory Committee of senior
faculty at CU Anschutz experienced at leading training grants.
The appointments for the Jointly Sponsored Predoctoral Training Program are for the first two years of
predoctoral training. As in the prior funding period, we seek to have six student appointees every year, split
evenly between first- and second-year students. We are requesting five years of support. The funded student
slots will help us meet the research needs of a dynamic and growing neuroscience community at CU Anschutz
and is, moreover, justified based on the demonstrated success of our prior trainees.

Public health relevance
Project Narrative The purpose of this grant is to provide financial support for the training of Neuroscience Ph.D. students in their first two years of graduate school. Graduates who emerge from our program will be qualified to conduct independent research in basic neuroscience at a variety of levels, as well as in disorders of the nervous system. The development of therapies for brain disorders is dependent on a well-trained workforce of neuroscientists.